GENETIC ANALYSIS OF SUSCEPTIBILITY TO COPD EXACERBATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Abstract of project: The primary goal of the project is to investigate the genetic determinants of COPD exacerbations, using a candidate gene approach, in a cohort of African American subjects with severe COPD, with and without COPD exacerbations.